Canvass: revitalizing and advancing the translation of natural products research

During this period, NCGC completed solicitation of natural products from external collaborators and screened the compiled natural product library against the full panel of diverse Canvass assays. Validation and characterization of this activity is currently being pursued. As a center, the NCGC has fostered and maintained over 130 active collaborations with both NIH and extramural investigators, facilitating drug discovery efforts across the entire spectrum of human disease. These efforts have led to dozens of high-throughput screens and a number of medicinal chemistry campaigns to further improve on screening hits, providing our collaborators and the general research community with publications and a variety of promising small molecule probes and leads. In addition, the NCGC has worked to advance a number of informatic initiatives to make better use of existing drug and disease target information and provide the general public with easily accessible resources, further catalyzing the development of new therapies for human disease.